A generalizable model of normal tissue recovery to enable personalized re-irradiation

Our current clinical approach to re-irradiation is not based on data. Guidelines vary widely and are not rooted in
observed toxicities. A frequently cited reason for that is both the scarcity of existing outcome data, as well as its
heterogeneity: there are multiple radiation courses per patient with variable time between treatments. It is correct
that the lack of data is a severe problem, though one that will be solved given the steep increase in the number
of re-irradiation cases and published data. What the current lack of data obscures is a much more fundamental
problem: that even if we had enough outcome data, there is no conceptual framework or outcome model to fit
that data to. The need for such an approach to guide clinical treatment of re-irradiation is urgent. While re-
irradiation used to be rare, patient volumes are growing rapidly: studies report that already 1 in 6 patients that
come for radiotherapy have received prior radiation to the involved or a nearby site.
To overcome the challenges described above, we propose a novel approach to guide re-irradiation based on
imaging the evolution of normal tissue damage and recovery. In this space, data is more plentiful, with imaging
at defined, clinically relevant follow-up timepoints. Furthermore we can build on our success in describing and
analyzing normal tissue response to radiation.
To overcome the challenges described above, we propose a novel framework to guide re-irradiation based on
two innovative concepts: 1) Quantifying the evolution of normal tissue damage and recovery after RT. The time
factor that is so important in re-irradiation can be studied using the evolution of radiation-induced normal tissue
damage on imaging. 2) Normal tissue radiosensitivity in an individual patient is conserved between RT courses.
While this seems intuitive, it is not known if normal tissue response in patients correlates when re-irradiating
them. We have unique preliminary indicating that there is a strong relationship, and proving this hypothesis would
enable us to integrate the response to the first treatment into the planning of the second.
Based on these two concepts we formulated our two independent aims. In SA1 we will describe normal tissue
recovery based on follow-up imaging using imaging biomarkers of liver and lung injury after radiotherpay. We
hypothesize that we can parameterize the dose-dependent recovery from radiation-induced injury using a single,
patient-specific recovery parameter in normal liver (SA1a) and lung (SA1b) after radiotherapy. In SA2 we will
explore feasibility of personalization of re-RT based on the observed normal tissue response at first RT. Our
working hypothesis is that the observed radiation-induced image changes after the first RT predicts normal tissue
response at second RT, when corrected for the initially given dose distribution.
Upon completion of these aims we will possess a generalizable framework for re-irradiation that allows us to
incorporate the patient’s individual response to the first radiation treatment, and the time that has passed since,
into the planning of re-irradiation.

Public health relevance
Our current clinical approach to re-irradiation is not based on data, as guidelines vary widely and are not rooted in observed toxicities. This proposal aims at developing a novel re-irradiation framework integrating the patient’s response to the first treatment and the time the organ had to recover. This proposal will advance knowledge how to incorporate the patient’s individual response to the first radiation treatment, and the time that has passed since, into the planning of re-irradiation, which is crucial to control for the variability among patients to enable correct interpretation of toxicity data.